Characterization and membrane-biogenesis of Streptococcus mutans magnesium transporters

Project Summary
Dental caries is a ubiquitous infectious disease that impacts the quality of life of billions of people
worldwide. According to the Surgeon General (2020), ~USD 125 billion dollars are spent annually on
related treatments in the USA alone. A major causative agent of dental caries is Streptococcus mutans,
which is also associated with infectious endocarditis. The native environment of S. mutans is rich in
metal cations including Ca2+, K+, and Mg2+. In fact, Mg2+ is the most abundant divalent metal cation in
bacteria and fourth most abundant in vertebrates including humans. Of the total Mg2+ content in the
human body, 60‐70% is found in bones and teeth. Therefore, the oral bacterium, S. mutans, is
constantly exposed to Mg2+ salts. Magnesium is an important component of toothpastes and dental
implants. Despite its abundance and its requirement to support bacterial growth and virulence , Mg2+
homeostasis has not yet been studied in S. mutans, or other oral streptococci. A few isolated studies
discussed the significance of supplemental Mg2+ salts for S. mutans biofilm formation and genetic
competence, but Mg2 transport is not understood. We will address Mg2+ homeostasis from a novel
perspective, where we will not only characterize the transporters, but also study their insertion into
the membrane. Membrane localization/insertion is a key requisite for the proper functioning of all
membrane proteins. Deletion of putative transporters singly and in combination, followed by
measurement of cellular metal content will establish identity of Mg2+ transporters. Compensatory
uptake/efflux by other divalent metal cation transporters have been recognized to interfere with Mg2+
homeostasis in other bacteria. Therefore, Mn2+ and Fe2+ transporters are also included in this study.
Mutants defective in putative Mg2+ transporter(s) will be evaluated at the level of transcription,
cellular metal content, and insertion into membrane. Next, we will use a forward genetic screen to
identify gain of function/suppressor mutations in Mg2+‐replete/deplete conditions using mutants
defective in Mg2+ transporters, or in mutants lacking membrane biogenesis machinery components
that impact Mg2+ homeostasis. We appreciate the significance of proper localization of transporters to
their activity; therefore, we will apply the experience/tools/skills of our lab to study that aspect of
magnesium homeostasis in S. mutans. Characterization of insertion pathways will involve
construction and characterization of combinatorial mutants of membrane biogenesis components
with Mg2+ transporters, and phenotypic analysis following that used for characterization of the
transport mutants. Molecular cloning, reverse and forward genetics, bioinformatics, and biochemical
approaches will be utilized to address the aims of this proposal. Ultimately a better understanding of
Mg2+ homeostasis in S. mutans is expected to guide future development of novel anti‐caries strategies.

Public health relevance
Project narrative The oral pathogen Streptococcus mutans is the primary causative agent of human dental caries, and can also cause infective endocarditis. Annual health care costs related to dental caries in the US alone exceed 125 billion dollars. Magnesium is the most abundant divalent metal cation, and is essential for survival and virulence of S. mutans, therefore Mg2+ homeostasis needs to be understood. The proposed work will explain Mg2+ homeostasis not only by characterizing putative transporters, but also by understanding the mechanisms underlying their insertion into the bacterial membrane.